Enhancing Efficacy of Migraine Self-Management in Children with Comorbid Insomnia

PROJECT SUMMARY ABSTRACT
Migraine is a major pediatric health problem impacting 10-12% of youth. Poor sleep is a common comorbidity,
particularly insomnia symptoms, which are reported by 65-71% of adolescents with migraine. Insomnia
contributes to greater headache-related disability, more frequent headache, higher pain intensity, greater
anxiety and depressive symptoms, poorer quality of life, and increased health care use. History of childhood
migraine places youth at risk for a lifelong pattern of migraine and disability and high health care costs in
adulthood. Thus, finding effective methods that support youth in the self-management of migraine is a priority.
Cognitive-behavioral therapy (CBT) for pain is an established treatment approach for youth with migraine;
however improvements in sleep are inconsistent. In fact, our preliminary data suggest that poor baseline sleep
is a risk factor for youth to achieve less improvement in pain outcomes with CBT for pain. Sleep and migraine
share a cyclical relationship, and data indicate that insomnia symptoms increase migraine severity in adults
and children. CBT for insomnia has demonstrated efficacy for improving insomnia symptoms in adults with
migraine and other pain conditions, however, effects on pain have been inconsistent. Post-hoc analyses
suggest that changes in pain may occur only after there are sustained improvements in sleep, but this has
never been empirically tested. In the proposed study, we will address these gaps in knowledge by using an
innovative 2-Phase trial design to: 1) test efficacy of CBT insomnia intervention for youth with migraine and
comorbid insomnia, and 2) investigate how changes in sleep may modify response to CBT pain intervention.
We will study a cohort of 180 youth, ages 11-17 years, with migraine (with or without aura, chronic migraine)
and comorbid insomnia. In Phase 1, youth will be randomly assigned to receive internet-delivered CBT
insomnia intervention or internet sleep education control over 4-weeks. In Phase 2, all youth will receive
internet-delivered CBT pain intervention over 8-weeks. Assessments will occur at baseline, immediately after
Phase 1 intervention, immediately after Phase 2 intervention, and repeated 6 months post-intervention. The
primary outcome for Phase 1 is insomnia symptoms. The primary outcome for Phase 2 is headache-related
disability. Secondary outcomes are sleep quality and sleep patterns, headache frequency and pain intensity,
anxiety and depressive symptoms, and quality of life. Sleep hygiene and pre-sleep arousal will be assessed as
potential mediators. We will use a comprehensive multidimensional assessment of sleep and headache
including self-report questionnaires, ambulatory actigraphy monitoring, and 14-day daily diaries. Given the high
prevalence of insomnia in adolescents with migraine, extension of CBT insomnia intervention to this population
will address an important gap in clinical practice and in conceptual understanding of the relationship between
sleep and migraine. By testing a separate CBT insomnia intervention, we will be able to apply this treatment in
the future to other pediatric populations (e.g., cancer, arthritis) who commonly experience comorbid insomnia.

Public health relevance
PROJECT NARRATIVE Insomnia is common and highly comorbid among adolescents with migraine, impacting 65-71% of youth. The proposed project will determine efficacy of cognitive-behavioral therapy (CBT) for insomnia, as well as the combined effect of CBT insomnia and pain interventions, on reducing insomnia symptoms and headache-related disability in adolescents with migraine. Our long-term goal is to offer effective, tailored self-management interventions that can address migraine and co-morbid sleep problems in adolescence and disrupt a cycle of persistent, disabling migraine from continuing into adulthood.